Enhancement of user access at the ALS

This interagency transfer to the United States Department of Energy provides additional support for personnel, equipment and supplies for the operation of beamlines at the Advanced Photon Source at Lawrence Berkeley National Laboratory as user facilities for macromolecular crystallography.